A Control Theoretic Approach to Addressing Hippocampal Function

Understanding the interplay between sensory input, endogenous neural dynamics, and behavioral
output is key to understanding how the brain works at the level of neural computation. Hippocampal place
cells are an ideal system to investigate this closed-loop interaction, as they combine input from self-motion
cues and external landmarks to continuously update a dynamic neural network that creates an internal
representation of location on a cognitive map. The normal functioning of this system is critical for such
cognitive processes as flexible navigation, imagining the future, and autobiographical (episodic) memory.
Animals can localize themselves by keeping track of their movements and continuously updating their
location on their cognitive map based on these movements—a process called “path integration.” In order for
this updating to coincide with the animal's actual displacement in the world, the relationship between
physical movement and position updating on the map must be fine-tuned. Previous work in a novel virtual-
reality environment demonstrated that external landmarks serve as a teaching signal to guide this fine-
tuning process through visual experience—a process called “path integration gain recalibration.”
The present proposal seeks an in-depth understanding of the neurophysiological mechanisms that drive
this previously unknown degree of plasticity in path integration dynamics, and how these mechanisms
support navigation. Attractor neural network models provide a compelling framework for understanding the
internal neural dynamic mechanisms underlying path integration. However, present versions of these
models do not capture the path-integration plasticity. Moreover, studying the nonlinear dynamics of how
visual inputs interact with the attractor network can provide important insights into how the brain creates
stable spatial representations that allow flexible solutions to spatial behavioral tasks. Principles and
analytical techniques of control-systems engineering will be applied to experiments that record the activity of
spatially tuned neurons from the hippocampus and related brain regions of rats to address a series of both
hypothesis-driven and discovery-driven aims: in Aims 1 and 2 we will investigate neurophysiological
mechanisms and behavioral consequences of the plasticity of the path integration computation and in Aims
3 and 4 we will investigate the signals (such as error signals) that underlie the interactions between
landmarks and path integration in the hippocampus that likely drive this plasticity. These experiments will
provide fundamental insight into how the brain computes representations of the spatiotemporal context of
an organism's experience, which is thought to constitute the framework that the brain uses to organize,
interrelate, and bind the various aspects of an experience and store them as a coherent memory. Such
insight will help understand how neurodegenerative disorders, such as Alzheimer's Disease and other
dementias, produce the devastating loss of cognitive function that is the hallmark of these diseases.

Public health relevance
Discoveries from basic systems neuroscience demonstrate that external senses (such as vision) interact with the internally generated, cognitive representations that underlie thoughts, perceptions, experience, expectations, and so on. Cognitive disorganization and memory loss are devastating consequences of numerous forms of neurological and psychiatric disorders, including Alzheimer's Disease, stroke, and schizophrenia. These experiments will provide crucial information about the neural mechanisms that allow information from the external senses to interact adaptively with internally generated, cognitive representations, providing insight into how these processes are disrupted in neurological and psychiatric disease.